Neuronal Circuit Maintenance in Healthy Aging

Project Summary
The overarching goal of this study is to identify new mechanisms that preserve neuronal function with age.
As the world's aging population steadily increases, the number of diagnoses for neurodegenerative disease
and dementia is projected to more than double within the next 30 years, underscoring our immediate need to
understand the cellular and molecular basis of brain aging. Atrophy of the connections that mediate neuronal
communication leads to aberrant activity within neural circuits in the aging brain. How changes in activity
modify the properties of aging neurons is not yet clear. The brain adapts to neuronal activity in part via the
induction of new gene expression programs encoding critical cell-type-specific mediators of circuit plasticity.
Whether re-engaging the regulators of these gene programs in aging brains can ameliorate declining neuronal
function remains unknown.
The bHLH-PAS transcription factor NPAS4 constitutes a major regulator of activity-dependent gene
programs in both mice and humans. NPAS4 integrates into the NuA4/TIP60 acetyltransferase protein complex,
a transcriptional co-activator and DNA repair complex, which has been linked to learning and memory in
invertebrates. Intriguingly, activity-dependent elements targeted by NPAS4 transiently acquire a chromatin
mark of DNA damage signaling upon neuronal activation (γH2AX), raising the possibility that NPAS4 may
function at these sites to help repair damage resulting from activity-driven transcription. In preliminary data, I
discovered that Npas4 knockout mice die prematurely with signs of cell stress in the hippocampus. This study
will examine the hypothesis that the newly identified NPAS4:NuA4 complex has evolved a protective role to
promote the sustained functionality of neurons by maintaining transcriptional control and genome stability at
activity-dependent gene loci. I will examine age-dependent changes to Npas4 regulation and activity-
dependent gene induction across neuronal cell types (Aim 1, K99) and identify critical gene targets of this
complex in activated neurons (Aim 2, K99). During the R00 phase, I will expand upon these ideas to explore a
novel role for this activity-dependent protein complex in the repair of directed DNA damage at enhancers and
promoters, and will examine how this directed DNA repair activity changes with age (Aim 3, K99). In the long
term, I will leverage the datasets, and new skills in bioinformatics and neurobiology acquired during the K99
training period, to identify new mechanisms and molecules that preserve cell-type-specific function in the
nervous system. My ultimate goal is to design targeted strategies to slow or reverse decline in the neuronal
subtypes most susceptible to age-dependent diseases.

Public health relevance
Project Narrative Our aging population is expected to develop increased incidences of neurodegenerative disease and dementia, but the molecular mechanisms that underlie these complex processes remain poorly understood. This proposal aims to understand how neuronal activity-dependent gene expression and DNA damage repair can regulate brain aging by leveraging a newly identified neuronal-specific protein complex, NPAS4:NuA4. These experiments will lay critical groundwork for designing targeted strategies to slow or reverse decline in the neuronal subtypes most susceptible to age-dependent diseases.